Dynamics and evolution of synthetic and natural gene regulatory networks

Project Summary: Administrative Supplement to NIGMS MIRA R35GM122561
Parent project title: Dynamics and evolution of synthetic and natural gene regulatory networks
This Administrative Supplement is based on NOT-GM-24-021, “Notice of Special Interest (NOSI):
Administrative Supplements for Equipment Purchases for Select NIGMS-Funded Awards”. It is a
request for support for a “Jess” automated capillary-based western blot system by Bio-Techne, which
allows for rapid, quantitative, highly reproducible, and multiplexed detection of up to 12 protein targets
in a single sample without a need for genetical modification. These capabilities will be crucial for the
parent project, which aims to learn how perturbed gene regulatory network dynamics and
stochasticity affect single cells and thereby cell populations. To achieve this, we proposed using
synthetic gene networks to generate specific gene expression patterns in space and time that serve
as perturbation signals for natural gene networks, to study the subsequent effects on cell population
behavior and evolution by computational modeling and experimental evolution. Unlike RNAs, which
are relatively easy to quantify by sequencing, multi-protein quantification is still a challenge. Upon
synthetic biological perturbation, the Jess system will uniquely unveil native regulatory network states
at the protein level so that we can link them with cellular phenotypes. Overall, the Jess system will
provide unique capabilities to illuminate at the protein level how regulatory networks enact control
across scales of space and time in biology, from molecules to cells. This information will help us
control adapting cell populations, which is relevant for understanding, predicting and possibly
mitigating cancer and microbial drug resistance.

Public health relevance
Narrative: Administrative Supplement to NIGMS MIRA R35GM122561 Parent project title: Dynamics and evolution of synthetic and natural gene regulatory networks This Administrative Supplement is a request for support for a Jess automated capillary-based western blot system by Bio-Techne, which allows for rapid detection of up to a dozen proteins in a single sample in a quantitative, highly reproducible manner, without a need for genetic modification. The Jess system will enable quantitative measurements of how synthetic biological control of genes affects protein levels, to be linked with cellular phenotypes. This will remove a bottleneck by providing information rapidly on multiple protein levels that can be further investigated to understand the network-level effects of synthetic biological perturbations, as proposed in the parent project.